Core B Clinical

CLINICAL CORE – CORE B: PROJECT SUMMARY/ABSTRACT
The BIOCARD study is a longitudinal, observational study of 349 individuals who were cognitively normal and
primarily middle aged (mean age=57.1) at enrollment. The subjects have now been followed for up to 27 years.
The overall objectives of the project are to further advance the study of preclinical Alzheimer’s disease
by: (1) clarifying the pattern and rate of change in AD biomarkers (including those based on CSF, blood, MRI,
and PET imaging) and cognition; the biomarkers to be studied include several promising novel biomarkers
derived from blood, CSF and brain imaging. (2) maximizing our data by working collaboratively with several
research groups who have comparable data, and (3) providing a publicly accessible data, brain scans, and
biological specimens, for researchers in the field. To accomplish these goals we established 7 Cores and, with
this application, are also including 2 projects. The Clinical Core (Core B) has a wide range of
responsibilities related to the evaluation and follow-up of the subjects in the BIOCARD study. The
specific aims include: (1) screening and enrollment of the new study participants, (2) scheduling subjects for all
visits and all study procedures, (3) completion of the annual clinical and cognitive assessments and consensus
diagnoses, and accompanying subjects to all additional study procedures, (4) acquisition of ante-mortem
autopsy approval, (5) assistance with subject retention activities, (6) analysis of the clinical and cognitive data
and working with other Cores and Projects to integrate the clinical and cognitive data into their analyses, and
(7) working with the Informatics Core to assure that the clinical and cognitive data shared with outside
investigators is as accurate as possible.